Elucidating and engineering eleutherobin biosynthesis

Project Summary/Abstract
Eleutherobin (1) is a diterpenoid marine natural product (MNP) isolated from octocorals. As
a potent microtubule stabilizing agent, 1 shows growth inhibition toward cancer cell lines
with potency comparable to paclitaxel but with reduced cross-resistance toward B-tubulin
mutants. Currently, a sustainable supply of 1 has not been accessed through wild harvest,
aquaculture or total synthesis. A synthetic biology approach toward 1 has been considered
as a possible alternative, but the native pathway remains elusive. Thus, the biosynthesis of
1 provides a challenging research opportunity in need of novel and creative ideas. Recently,
our group has reported the characterization of a key terpene cyclase, EcTPS1, from a
producer of 1, E. caribaeorum. Furthermore, the EcTPS1 gene was found to be flanked by
predicted oxidase and acylase genes on an animal chromosome. This unprecedented,
putative biosynthetic gene cluster (BGC) provides a clear direction for reconstituting
biosynthesis of 1. Our underlying hypothesis is that by using our characterized EcTPS1 as a
starting point we can produce 1 using a combination of chemical and enzymological
methods. The overall goal of this proposal will be to engineer heterologous production of
precursors to 1, characterize the tailoring enzymes in the BGC and employ these in a semisynthesis
of 1. This work will provide innovation in the field biochemistry by further
developing tools in secondary metabolism as well as affording commodities in the form of
sustainable natural product supply and novel biocatalysts. Three essential challenges
toward these efforts are: 1) No synthetic biology route or other sustainable approach to a
eunicellane precursor exists; 2) Installation of oxygenated functional groups by chemical
synthetic means will require stereo-, regio- and chemoselective methods. 3) The tailoring
enzymes of the biosynthetic pathway are biochemically challenging membrane bound
proteins. These challenges will be addressed using organic synthesis and synthetic biology
as outlined in the following specific aims: Aim 1) Engineering a semi-synthetic route toward
eleutherobin; Subaim 1 a) Synthetic biology route to the eunicellane precursor klys implexin
R; Subaim 1 b) Chemical synthesis of the eleutherobin core: Aim 2) Characterization of
tailoring enzymes in the eleutherobin biosynthetic pathway; Subaim 2a) Characterization of
cytochrome P450 enzymes; Subaim 2b) Characterization of acyl transferase enzymes.

Public health relevance
Project Narrative This project aims to use the genetic blueprint for molecules made by sea corals to produce chemotherapeutic drugs for cancer. We will study the fundamental biochemistry of these animals to design new tools to make medicines.